The Relationship Between Sex and Progression of Retinal Degenerative Disease

PROJECT SUMMARY.
Neurodegenerative disorders represent major sources of human suffering, yet the factors influencing disease
severity remain poorly understood. Sex has been implicated as one such factor, yet there remains a considerable
gap in our understanding of how sex hormones affect neurodegenerative processes. Retinitis pigmentosa (RP)
is a retinal neurodegeneration in which photoreceptors undergo a progressive and irreversible degeneration
leading to blindness. We recently discovered that females have a worse outcome than males in a mouse model
of RP caused by the rhodopsin P23H mutation (Rho P23H), the most common cause of autosomal dominant RP
in humans. Further, we showed that this association is caused by an adverse effect of circulating female sex
hormones on retinal neurons, which can be ameliorated by depletion of these female hormones. RP can be
caused by a wide diversity of genetic mutations, which creates a daunting obstacle to therapeutic targeting of
each individual mutation. However, many of these mutations result in similar phenotypes and converge on
shared downstream pathways leading to photoreceptor neurodegeneration. The objective of this proposal is to
determine the molecular mechanisms by which female sex hormones adversely impact the severity of
photoreceptor neurodegeneration. To investigate how the female sex hormones play a role in this common
pathway of photoreceptor neurodegeneration, we propose to expand on our work in the Rho P23H RP mouse.
We hypothesize that female sex hormones interact with key cell death and cell stress pathways downstream of
the genetic mutation, to worsen photoreceptor degeneration. The findings from these aims will provide novel
insights into how sex hormones modulate the pathogenesis and severity of neurogenerative disease. Results
from these aims will identify the precise female hormones and any interconversions of these hormones driving
advanced retinal degeneration in RP, and the mechanism by which this occurs. These findings have far-reaching
implications for clinical trial design, such as sex stratification, hormonal medications, consideration of pre-, peri-
, and post-menopausal states, and the use of hormonal therapy in females with certain neurogenerative
disorders such as RP.

Public health relevance
PROJECT NARRATIVE. Sex differences have been found to play critical roles in the pathogenesis of neurodegenerative diseases, such as leading causes of retinal degenerative disease worldwide. We have discovered that female sex is a risk factor for worsened outcomes in a model of retinal degeneration, that this susceptibility is caused by the presence of female-specific circulating sex hormones, that the adverse effect of female sex hormones was specific to diseased retinal neurons, and that depletion of these hormones ameliorated this phenotypic effect. This grant proposal takes the next steps to determine the mechanisms by which the female sex hormones interact with the retinal neurons to drive this disease progression, and results from these aims will provide critical insight into treatment and monitoring strategies for male and female patients with these diseases, as well as potential approaches for future therapeutics targeting the sex hormone pathways in the retina during retinal degenerative disease.